Investigating the Role HIV Viral gRNA and Gag-Pol Incorporation in HIV-1 Maturation

Project Abstract:
HIV is a continual threat to public health. Despite advances to prevent infection and slow disease progression,
no definitive cure exists for this deadly virus. Existing treatments for HIV target essential viral proteins and
enzymes, such as protease, reverse transcriptase, integrase, and viral capsid interactions, all of which
contribute to the successful delivery of an infectious virus to the next host cell. While the major roles of these
enzymes are well understood, the mechanism of their incorporation during viral assembly as part of the
Gag-Pol polyprotein has yet to be defined. Preliminary data from the Saffarian Lab shows a mix of mature and
immature Virus-Like Particles (VLPs) from expression of an NL43 backbone with a Psi (Ѱ) packaging signal
deletion, NL43(Ѱ: Δ(105-278)&Δ(301-332)), in HEK293 cells. The Psi packaging signal deletion reduces viral
gRNA incorporation during assembly, but the effect of the deletion on maturation efficiency has not been
defined. This finding highlights the need for further investigation of the mechanism of Gag-Pol incorporation
and the possible role of viral gRNA in maturation efficiency. This proposal aims to test two hypothesis to
address these unknowns: Hypothesis 1- An unknown Gag-Pol packaging mechanism is disrupted by removal
of the psi packaging signal, (Δ(105-278)&Δ(301-332)), resulting in VLPs lacking sufficient Gag-Pol for
maturation. Hypothesis 2- There is a role for gRNA in protease activation, and virions that did not mature did
not have sufficient gRNA or cellular RNA’s incorporated. Aim 1 will investigate the mechanism of Gag-Pol
incorporation by examining the fluorescence of labeled Gag-Pol proteins in purified HIV VLPs. Aim 2 will
uncover the role of viral gRNA in virion maturation efficiency by leveraging lentiviral vector systems to
selectively incorporate gRNA domains into minimally viable VLPs. These VLPs will be examined for maturation
efficiency using advanced Cryo-Electron Tomography and subtomogram averaging. These experiments will
provide training in advanced fluorescent light microscopy, Cryo-Electron Tomography, and complimentary
biochemical assays. Additionally, exposition of the proposal findings will offer experience in oral and written
scientific communication by attending and presenting at conferences and publishing in high quality journals.
These skills will serve the fellow as an independent researcher following the conclusion of the fellowship.
Finally, the findings of this proposal stand to elucidate essential HIV maturation mechanisms, opening avenues
for drug targets and advanced treatment for HIV.

Public health relevance
Project Narrative: HIV is a continual threat to public health which, despite advances to prevent infection and slow disease progression, has no definitive cure. Many existing treatments target enzymes essential for delivery of infectious HIV virions, including protease, reverse transcriptase, and integrase; however, the mechanism governing incorporation of their host polyprotein, Gag-Pol, and the function of viral gRNA in HIV maturation efficiency are not defined. This proposal aims to understand the mechanism of Gag-Pol incorporation via fluorescent light microscopy and elucidate the role of viral gRNA in viral maturation efficiency via Cryo-Electron Tomography, opening avenues for novel drug targets and advanced treatment of HIV.